Post-doctoral HIV Research Training Program for HIV Combination Prevention

? DESCRIPTION (provided by applicant): This T32 HIV training grant aims to attract, fund, and train 12 post-doctoral trainees over 5 years who can be leaders in developing and implementing a novel behavioral and social science agenda for combination prevention, utilization of new technologies, and reducing health disparities in HIV. The specific goals of the two to three-year program are to: 1) provide focused, interdisciplinary mentoring to 12 post-doctoral trainees in the field of HIV prevention and treatment, especially in terms of conceptualization and design, writing, and project management; 2) engage trainees in two to three years of intensive hands-on research projects under the supervision of faculty mentors experienced in HIV research; 3) support trainees' development and implementation of their own research projects, leading to their own grant proposals and multiple publications; 4) link trainees to a broad network of HIV researchers, creating opportunities for later career advancement and knowledge of cutting edge research; and, 5) offer the opportunity for one additional course per quarter for one year to remediate deficit skills. Successful graduates of this training program will: Complete at least one research study or clinical research project in their training; Participate in day-to-day execution of several other projects under the mentorship of a faculty member; Present findings in at least one major scientific conference annually and multiple regional conferences; Publish at least three first-authored papers annually in leading journals and collaborate on other peer- reviewed papers; and, Receive a multi-year grant or career development award and an academic position on a topic related to HIV.

Public health relevance
PUBLIC HEALTH RELEVANCE: UCLA faculty devoted to HIV research aim to provide an innovative, behaviorally-focused, training experience to prepare and jump-start post-doctoral fellows to contribute the research on combination prevention, the use of mobile technologies and point-of-contact diagnostics, and reducing health disparities. With our collective experience and existing infrastructure funding for a center grant, the faculty have the resources and opportunities to work closely with six post-doctoral trainees annually to identify, develop, and evaluate efficacious, scalable, and cost-efficient HIV intervention strategies. Trainees will harvest from existing evidence-based HIV behavioral interventions to create novel strategies to optimize the impact of biomedical innovations.